Chemical approaches to interrogate neuropeptide and peptide hormone signaling in disease

PROJECT SUMMARY/ABSTRACT
Targeting neuropeptide and peptide hormone signaling is a promising strategy to treat a wide range of human
diseases, including neurodegenerative diseases, diabetes, osteoporosis, and cancer. A rigorous molecular-level
understanding of how specific peptide molecules signal in disease provides valuable information that can directly
inform the design of therapeutic compounds. However, there remain a large number of bioactive and disease-
relevant endogenous peptides whose signaling pathways are not understood. Because of the importance of
peptide-receptor interactions in normal physiology and disease, there is a critical need for new tools and
approaches to fully interrogate and modulate these signaling systems.
The long-term goal of my research program is to rigorously identify and evaluate novel molecular signaling
pathways as therapeutic targets. To achieve this goal, my research program pursues a highly interdisciplinary
approach, with expertise in the design, synthesis, and implementation of novel chemical probes and
peptidomimetics, protein and peptide mass spectrometry, and analysis of peptide-receptor interactions on cells.
Over the next five years, we are motivated by three broad research questions. 1) What are the receptors for a
given disease-related bioactive peptide? Our goal is to develop and implement new and unbiased chemical
approaches to directly detect peptide-receptor interactions without the need to genetically or chemically modify
the receptor prior to interaction. We will implement these approaches to identify receptors for three specific
peptide hormones with roles in obesity and diabetes. 2) How does peptide abundance and post-translational
processing influence disease? Our goal is to identify neuropeptide and peptide hormone interactions that can
be targeted to benefit human health. We are developing and applying mass spectrometry-based methods to
uncover the full complement of neuropeptides and peptide hormones in understudied disease-relevant
physiologies, including characterization of all post-translational modifications and rigorous quantitation. We will
use our strengths in chemical probe and peptidomimetic design to evaluate these new targets after initial
identification. 3) Are there new “non-traditional” approaches to modulating cell-cell signaling waiting to
be uncovered? Our goal is to explore naturally occurring peptide-receptor systems that function outside of the
traditional agonist/antagonist paradigm. Information gained from this research area will be utilized to develop
new chemical probes to better understand signaling events, and to inform the design of novel therapeutic routes
that may provide advantages over traditional modulators.
Overall, this research program will develop new tools and strategies to fully understand and modulate peptide
signaling pathways. This work will impact biomedical research by a) significantly advancing understanding of
neuropeptides and hormones in disease, b) identifying novel signaling pathways to target for treatment, and c)
generating chemical probes as the starting point for therapeutic agents.
Project Summary/Abstract Page 6

Public health relevance
PROJECT NARRATIVE Neuropeptides and peptide hormones act as messengers to facilitate communication between cells in the central nervous system and endocrine system. Because many human diseases are caused by a dysregulation of normal cellular communication, it is critically important for human health to fully understand and selectively modulate these signaling pathways. This research develops chemical probes and approaches to interrogate the molecular mechanisms of peptide transmitters in disease, which will reveal new targets for therapeutic intervention. Project Narrative Page 7